Automated widefield fluorescence microscopy system

Project Summary/Abstract
In this application, Eastern Washington University (EWU) proposes purchase of a Leica
Microsystems THUNDER Imager Live Cell, an automated brightfield, phase contrast, and
inverted fluorescence microscope with on-stage environmental chamber for endpoint and time-
lapse imaging. Research projects in bone cell biology, neurobiology, and microbiology
conducted by major users will leverage the instrument’s programmable automated imaging
protocols, multi-color fluorescence imaging, and computational clearing to interrogate cultured
to better understand mechanisms of bone homeostasis, brain function, and anti-microbial
agents. In addition to supporting current and future research projects, the system will support
undergraduate- and graduate-level courses in histology, microscopy, and cellular biology.
Consisting of the microscope, motorized stage, objective, filter, and environmental chamber
components, the Thunder Imager and its controlling computer will be housed in EWU’s newly
renovated microscopy shared-use lab, an interdisciplinary facility that will host research and
education activities from multiple departments including biology, geosciences, and chemistry.
This facility will provide preparation areas for specimen processing for scanning electron
microscopy and fluorescent and live-cell imaging with the proposed system. As part of a shared
facility, the Thunder Imager will be available for research and educational use to all members of
the EWU community and other institutions within the greater eastern Washington region, with
training and supervision provided by a committee composed of the project’s principal
investigator and major users. Acquisition of this system will enhance EWU’s research capacity
and contribute to a richer training experience for our students.

Public health relevance
Project Narrative This application proposes purchase of an environmentally controlled, computer operated microscope for live and static imaging of specimens using brightfield, phase contrast, and fluorescent illumination. This system will support Eastern Washington University’s research mission by enhancing capacity to conduct projects focusing on mechanisms of bone health and disease, brain function, and antimicrobial therapies. In addition, the system will support undergraduate and master-level coursework in microscopy to better prepare the next generation of clinicians and scientists.